Chromatin-based regulation of neural stem cells

Neural stem cells (NSCs) hold promise for the treatment of a wide range of neurological disorders
common to Veterans such as traumatic brain injury (TBI) and Parkinson’s disease. In addition to providing cells
for transplantation-based therapies, NSCs are also an important source of human neurons and glia for drug
discovery and development. To realize the full potential of NSCs for human therapy, it is important to understand
the molecular mechanisms that regulate the production of specific neural cell types. Our long-term goal is to
understand the cellular and molecular mechanisms by which NSCs produce specific types of neurons and glia.
The postnatal and adult mammalian brain harbors NSCs in the ventricular-subventricular zone (V-SVZ).
Importantly, V-SVZ NSCs retain distinct regional identities that dictate the production of different neuronal
subtypes. For instance, NSCs in the ventral V-SVZ produce neuron subtypes different from those born from
NSCs in the dorsal V-SVZ. How NSCs “remember” their regional identity has been unclear. Mixed lineage
leukemia-1 (Mll1) encodes a chromatin regulator that is part of an evolutionarily conserved transcriptional
memory system, and MLL1 is required for normal V-SVZ neurogenesis. Recently, we showed that MLL1 is
required for the maintenance of NSC regional identity. Even transient inhibition of MLL1 activity causes ventral
NSCs to “forget” their regional identity and generate neurons more typical of dorsal NSCs. This change in
developmental potential with transient MLL1 inhibition corresponds to persistent changes at the level of the
transcriptome and chromatin-state. The objective of this proposal is to understand the role of MLL1 in
maintaining NSC identity. Based on Preliminary Studies and our previously published data, our central
hypothesis is that MLL1 is required to maintain NSC identity via specific changes to chromatin architecture. In
this renewal application, we propose to investigate the function of MLL1 in maintaining key aspects of NSC
identity. Given that NSC identity is a critical aspect of their neurogenic potential, results obtained will have
important implications for our ability to produce specific types of neurons for human translational research and
transplantation therapies. The proposed studies may inform methods in which transient MLL1-inhibition is used
to broaden the developmental potential of NSC populations by “erasing” their regional and temporal identity.
Furthermore, these studies advance new basic, neurodevelopmental concepts regarding NSC identity, which
may be important to understanding how mutations in human MLL1 cause Weidemann-Steiner Syndrome, a
developmental disorder that includes intellectual disability and autism. Finally, discovering MLL1-dependent
mechanisms at genomic regulatory elements will likely be of interest to the broader fields of neurodevelopment,
epigenetics and stem cell biology. Our published results, Preliminary Studies, and expertise in V-SVZ and
chromatin biology support the feasibility of these Aims.

Public health relevance
Neural stem cells (NSCs) hold promise for the treatment of neurological disorders common to our Veteran population such as traumatic brain injury and Parkinson’s disease. Understanding the molecular mechanisms by which NSCs differentiate into specific types of neurons and glia is key to unlocking their therapeutic potential. Our overall goal is to determine the molecular mechanisms that regulate NSC biology. For NSCs to make neurons, daughter cells need to express certain sets of genes while repressing others. Such lineage- specific gene expression is in part regulated by chromatin structure – the “packaged” state of DNA. We plan to use cell biology and molecular approaches to investigate how a specific chromatin regulator called MLL1 coordinates the production of specific types of neurons from NSCs.